Personalized neuroblastoma vaccines

PROJECT SUMMARY
This Multiple Principal Investigator (MPI) Project proposal for the Pediatric Immunotherapy Network is focused
on high-risk neuroblastoma, a diverse and enigmatic malignancy arising from the developing sympathetic
nervous system that remains lethal in 50% of patients despite intensive multi-modal therapy. There is an urgent
unmet need for developing novel therapeutic interventions to decrease the incidence of relapse, increase overall
survival, and reduce devastating toxicities associated with standard therapy. The primary goal of this Project is
to achieve improved outcomes for patients with high-risk neuroblastoma through the development of a
personalized vaccination strategy targeting individualized neoantigens. The central hypothesis is that high-risk
neuroblastomas, despite a low tumor mutation burden (TMB), harbor a sufficient number of neoepitopes through
canonical and non-canonical mutations to identify, predict, and validate optimal neoantigen peptides to engineer
effective multivalent personalized neuroblastoma vaccines. The motivation for the proposed research is the
urgent need to improve survival and to decrease treatment-related morbidities for patients with high-risk
neuroblastoma. Indeed, the majority of high-risk neuroblastoma patients achieve a remission with standard
therapy, and here we seek to engage the adaptive immune system to eradicate residual disease and prevent
relapse. We will test our hypothesis through the two Specific Aims: 1) define the neoantigen landscape of high-
risk neuroblastoma patient and genetically engineered mouse model (GEMM) tumors; 2) develop and test a
readily translatable personalized vaccination strategy. In Aim 1 we will both provide the proof-of-concept that a
multivalent vaccine consisting of both CD4+ and CD8+ epitopes is feasible for each high-risk patient and also
credential our GEMM system for preclinical vaccination trials in Aim 2. We will use an integrative proteogenomic
approach to identify up to eight immunogenic peptides for each personalized vaccine. In Aim 2, we will test both
preventative and therapeutic efficacy of self-assembling nanoparticle multivalent peptide vaccines using our
GEMM system on the CB57BL/6 background, and then compare this vaccine platform to a new lipid-peptide
polymer vaccine system optimized to deliver peptides to dendritic cells. This Project proposes an innovative
experimental strategy to identify, prioritize, and validate neoantigens in high-risk neuroblastoma, and a clinically
relevant neuroblastoma GEMM system for preclinical evaluation of neuroblastoma vaccines. The significance of
the proposed Project is the creation and validation of a novel immunotherapeutic approach that has the potential
to revolutionize high-risk neuroblastoma standard of care by providing durable cures and decreased therapy-
related morbidity. The expected outcome of this collaborative MPI Project is to establish the preclinical proof-of-
concept for a personalized neuroblastoma clinical trial that we would seek to launch in the out years of this grant
given the infrastructure we have in place. The successful completion of this Project will also enable personalized
neoantigen-based vaccine development for other pediatric malignancies.

Public health relevance
PROJECT NARRATIVE This proposal is relevant to public health because it seeks to develop personalized anti-tumor vaccines, focusing here on the childhood malignancy neuroblastoma. The research is highly relevant to the NIH mission and the urgent unmet need of developing rational evidence-based therapeutic and relapse preventative strategies to reduce the health burden of cancer. This integrated multiple principal investigator project is designed to catalyze improved cure rates with decreased morbidity for patients with high-risk neuroblastoma, and many advances will be applicable to the field of cancer in general.